HIGH RESOLUTION OF STRUCTURAL STUDIES OF INSECT VIRUSES

We propose to continue our studies of insect viruses employing crystallography, molecular genetics, electron microscopy and computational and membrane chemistry to refine and extend models for virus assembly, maturation, cell attachment and genome delivery. Viruses with T=3 and T=4 quasi-equivalent capsids, as well as a picorna- like P=3 capsids will be used for the study. Crystallographic, biophysical and molecular genetic investigations of T=3 nodaviruses show that the capsid protein is modular in its function. The N-terminal portion controls the generic neutralization and condensation of RNA, while the C-terminal portion determines the specificity of RNA packaging. Autocatalytic maturation cleavage of the capsid protein, required for infectivity and creating a covalently independent, C- terminal module, is controlled by an internal helical domain, the quaternary structure of the capsid and the binding of divalent metal ions near the particle surface. Portions of the capsid protein and ordered duplex regions of the RNA genome function as molecular switches that lead to T=3 quasi-equivalence. Computational studies indicate that the particles assemble from a stable trimer intermediate and that there is conformational polymorphism between the formation of hexamers and pentamers of trimers that facilitate quasi-equivalent capsid formation. Biophysical investigations lead to a dynamic model for RNA uncoating in which the independent helical bundle, created during maturation, is associated with the 5' end of the RNA and is released from the particle when the virus binds to the receptor and enters the endosome. The model connotes that the helical bundle serves as conduit for membrane translocation of the 5' region of the viral RNA allowing the ribosome to initiate translation and drag the RNA through the membrane and into the cytosol. The hypothesis was strengthened when we demonstrated through structural and functional studies that a T=4 insect virus undergoes a maturation cleavage like the T=3 virus and that a pentameric helical bundle near the C-terminus was cut from the remainder of the coat protein. The cleavage site and helical bundle are nearly identical in the two different virus particles. We now propose to investigate issues of assembly through crystallographic studies of mutant virus-like particles generated in baculovirus expression systems for both virus families and to extend our computational studies of assembly. We will also identify and clone the soluble portion of the receptor for nodaviruses and attempt to make a virus receptor complex for cryoEM investigation. We will investigate the in vitro interaction of the virus particles with membranes and determine the structure of a picorna- like insect virus to see if there is evidence for functional and evolutionary similarity between T=3 ans P=3 particles.